Sema3C Signaling as an Alternative Activator of Canonical Wnt Signaling in Glioblastoma

PROJECT SUMMARY
The Wnt pathway is frequently dysregulated in many cancers, underscoring it as a therapeutic
target. Although Wnt inhibitors appear promising in many preclinical studies, they have failed
uniformly in clinical trials. Molecular mechanisms of resistance are poorly defined. Further
dissection of the precise mechanisms of WNT pathway activation in specific tumor types is
needed to develop new WNT pathway inhibitors with less toxicity. The axonal guidance program
Sema3C/PlxnD1 promotes the self-renewal and tumorigenicity of glioma stem-like cells (GSCs),
but the underlying mechanisms are unclear. Our data now suggest that Sema3C/PlxnD1 signaling
functions as an alternative activator of canonical Wnt signaling. Importantly, Sema3C-driven Wnt
signaling occurred despite suppression of Wnt ligand secretion, suggesting that Sema3C may
drive canonical Wnt signaling independent of Wnt binding to its receptors. As Sema3C/PlxnD1
signaling is used in over 85% of GBM, it may represent an important mechanism of resistance to
upstream Wnt pathway inhibitors. Our data support that Sema3C/PlxnD1 signaling regulates two
critical aspects Wnt signaling: beta-catenin stability and nuclear translocation. In this proposal,
we aim to identify molecular mechanisms by which Sema3C/PlxnD1 regulate canonical Wnt
signaling. Additionally, we aim to assess the therapeutic impact of targeting Sema3C signaling to
improve sensitivity to upstream Wnt inhibitors in mouse models of GBM. These studies will
provide a novel therapeutic strategy to achieve clinically significant Wnt pathway inhibition in
GSCs potentially without the toxicity of currently available WNT inhibitors. These studies may be
applied to other cancers including breast and prostate cancers that utilize both Sema3C and Wnt
signaling.

Public health relevance
PROJECT NARRATIVE Glioblastoma is an incurable primary brain tumor. The Wnt pathway is frequently dysregulated in many cancers, including glioblastoma, underscoring it as an important therapeutic target. This work will reveal a novel mechanism by which Wnt signaling is activated independent of Wnt ligand-receptor binding. If successful, the findings of this study will provide new strategies to improve treatment for glioblastoma.